Microsatellite Instability Sequencing via Single-Molecule DNA Re-Reading

Project Summary
Oncologists have a great need for improved DNA sequencing technology because sequencing the DNA of cancer
cells can provide valuable information about the specific mutations driving the disease and inform/guide
treatment decisions. Additionally, sequencing healthy tissue can provide information about an individual's genetic
risk factors for cancer. One area of particular interest is repetitive DNA sequences called microsatellites, which
undergo a high level of polymorphism, defined as microsatellite instability (MSI). MSI is a type of genetic
alteration that is often found in many cancer cells, especially in certain types of tumors, such as colorectal cancer.
The detection of MSI is important for the diagnosis and management of cancer patients. For example, MSI-high
tumors are more responsive to immunotherapy, a type of cancer treatment that boosts the body's immune system
to attack cancer cells. Therefore, accurate microsatellite sequencing is crucial for oncologists to make informed
treatment decisions for their patients. Currently available DNA sequencing technologies, such as Sanger
sequencing, next-generation sequencing (NGS), and single-molecule sequencing (SMS), all have limitations
when it comes to accuracy, cost, and scalability. During this Phase I SBIR program, Electronic BioSciences, Inc.
(EBS) will be developing a “Fourth Generation” DNA sequencing technology that enables de-novo, ultra-high
accuracy sequencing, specifically targeting microsatellites for oncology applications. This project directly
leverages recent advances in nanopore-based sequencing and single-molecule strand control/manipulation to
enable the direct, continuous re-sequencing of individual DNA molecules, which will enable unprecedented levels
single-molecule sequence coverage and subsequent high-accuracy sequence determinations during sample
profiling/screening. The technology developed during this project will enable the confident detection of MSIs with
greater precision than any currently available methods. The system will also be automated and scalable for
eventual high-throughput sequencing. Further, to validate the sequencing improvements achieved during this
project, the developed technology will be benchmarked against currently available approaches. Ultimately, this
project has the potential to significantly advance the fields of oncology and cancer genomics by enabling the
accurate and efficient sequencing of DNA, including challenging microsatellite regions, which can serve as critical
biomarkers for cancer diagnosis and prognosis, and guide the development of effective therapeutic interventions.

Public health relevance
Project Narrative This project will yield the development of a new fourth-generation DNA sequencing technology (based on the ability to obtain sequencing coverage on a single molecule, an unprecedented capability) capable of ultra-high accuracy microsatellite sequencing and profiling, which will enable personalized, effective cancer diagnostics and therapy intervention strategies. The ability to sequence and profile microsatellites (and associated microsatellite instabilities) with high accuracy and efficiency will significantly advance genomics, especially for oncology and cancer research, where improved sequencing accuracy is needed to propel cancer genomics and epigenomics to the foreground of cancer diagnostics, prognostics, and therapeutic intervention decision making, ultimately saving lives.